Home-Based Transcutaneous Auricular Vagus Nerve Stimulation (taVNS) for Pain and Symptom Management among Young Adults with Irritable Bowel Syndrome (IBS)

PROJECT SUMMARY
Irritable bowel syndrome (IBS) is a functional gastrointestinal condition caused by a disruption in the brain-gut
interaction and psychological factors such as stress and anxiety contribute to the onset and severity of the
symptoms of IBS that typically manifests in the early adult years and detrimentally impacts mood, quality of life
(QOL), and employment. Pain is the most distressing symptom reported by individuals with IBS, and it greatly
impacts their overall health. While non-pharmacological pain management strategies have shown promise in
diverse populations and regions, their feasibility and practicality in the context of young adults (YAs) with IBS
remain underexplored. Home-based transcutaneous auricular vagus nerve stimulation (taVNS) targets the
auricular branch of the vagus nerve, aiming to modulate nervous system activities and restore normal vagal tone.
This mind and body intervention offers a nonpharmacologic, noninvasive, and portable approach, demonstrating
promising therapeutic effects in alleviating IBS-related pain and symptoms in YAs. This pilot randomized
controlled study aims to evaluate the feasibility, acceptability, adherence, safety, and potential
implementation barriers of home-based taVNS intervention in YAs (18-29 years old) diagnosed with IBS.
A two-site, two-arm, parallel, proof-of-concept randomized trial will be conducted to assess the feasibility of using
the Active taVNS intervention compared with Sham taVNS in managing IBS-related pain and symptoms. Eighty
YAs meeting the Rome IV diagnostic criteria of IBS will be recruited and receive either Active or Sham taVNS
for pain and symptom management, along with self-management education and their usual treatment and care.
After enrollment and a 2-week baseline run-in period, participants will be randomized to the Active or Sham
taVNS with a 6-week treatment (30 minutes per session, twice daily for 6 weeks) and be followed up for another
6 weeks of post-treatment. We will assess feasibility through recruitment rates, adherence, factors influencing
adherence, safety, satisfaction, and collection of patient-reported outcomes. This innovative home-based taVNS
intervention aligns with the National Center for Complementary and Integrative Health's (NCCIH) mission to
improve pain management through mind and body interventions. The data from this trial will inform the
development of large-scale studies, ultimately enhancing pain management strategies, quality of life, and overall
health for YAs with IBS.

Public health relevance
PROJECT NARRATIVE The aim of this pilot randomized controlled trial is to assess the feasibility, acceptability, adherence, safety, and potential implementation barriers of transcutaneous auricular vagus nerve stimulation (taVNS) in young adults (YAs) diagnosed with irritable bowel syndrome (IBS). Home-based taVNS offers a nonpharmacologic, noninvasive, and portable method with promising therapeutic effects in improving IBS-related pain and symptoms. The findings of this study will be crucial in enhancing our understanding of the feasibility of using this innovative mind and body strategy, potentially paving the way for more effective treatments within the IBS population.